Bytes to Bedside: Collaborative Development for Translational Clinical Decision Support

PROJECT SUMMARY
Clinical decision support (CDS) systems were developed to improve the quality and safety of medical practice.
At present, however, these systems are generally not tied to clinical outcomes, decreasing their effectiveness.
Additionally, CDS is often built one institution at a time, so effective CDS does not scale and achieve its
potential. Our proposed study aims to expand existing CDS metrics and data sharing infrastructure across six
CTSA hubs. In doing so, this study seeks to fully realize the effectiveness of CDS systems through the
leveraging of electronic health record (EHR) data and ultimately reducing the barriers to highly efficient data
interoperability. Our hypothesis is that the development of translational metrics and data sharing infrastructure
across multiple institutions will address both translational science and research barriers, increasing the
efficiency and effectiveness of CDS, and improving clinical outcomes. Through this study, we will create a
centralized and highly efficient data-sharing infrastructure to support translational clinical decision support
analysis and benchmarking of performance across sites. We will ground our work in the EPIS Framework,
which consists of Exploratory, Preparation, Implementation, and Sustainment phases. The EPIS conceptual
framework is well-known, reliable, efficient, and scientifically valid for our approach. We will ground the work
from all five aims (across both the UG3 and UH3 phases) in this framework, testing our approach for gains in
efficiency, collaborative performance, and translational outcomes. In the UG3 Phase (Aims 1-3) we will create
the processes and governance for the Translational CDS Collaborative, build the analytical infrastructure and
test its performance, and establish feasibility of the collaborative beyond the initial study sites. After reaching
our milestone goals, we will progress into the UH3 Phase (Aims 4-5), which will evaluate the impact of the
collaborative on clinical outcomes and expand the capabilities and impact of the infrastructure.
The proposed work will set the foundation for efficiently and effectively creating, disseminating, implementing,
and evaluating electronic CDS. We will create a centralized collaborative learning platform and shareable
resources for CTSI sites, acting as an innovation nidus for the entire informatics and clinical research
community, enabling data-driven CDS design recommendations and frameworks. This CTSA-sponsored
project will aggregate the expertise, talent, and resources we have at our individual sites into a collective
program that is designed to reframe CDS as a translational catalyst and enabler. The multi-site foundation we
propose will serve as the starting point for the development of next-generation analysis of CDS data, the
effective design of impactful CDS-based interventions, and innovative approaches to solving some of the
largest challenges in modern informatics and clinical practice.

Public health relevance
NARRATIVE Current models of operations and research involving clinical decision support (CDS) are too site-specific, not scalable, and do not measure translational outcomes. We propose to create a collaborative infrastructure centered around reusable CDS metrics that more effectively measures clinical outcomes and compares these benefits against the tradeoffs of alert burden and fatigue. Through our collaborative approach across ten CTSA Hubs, this study will be the first to use a translational science approach to understand the impact of CDS systems.